Targeting Tubular Mitochondrial Superoxide Dismutation in Cisplatin Renal Repair

SUMMARY
Treatment with the chemotherapy drug, Cisplatin, frequently results in developing and/or progressing chronic
kidney disease (CKD). Cisplatin accumulates in renal proximal tubular cells, which reabsorb nutrients and
metabolize Cisplatin to reactive thiols that cause oxidative damage. Injured tubular cells that fail to repair are
known drivers of progressively declining kidney function and show impaired mitochondrial oxidative metabolism.
We have supportive evidence demonstrating that GC4419, a mitochondrially targeted superoxide (O2•–)
dismutase (SOD) mimetic, protects the kidney against oxidative stress and cisplatin-induced CKD in mice and
humans. GC4419 also reverses electron transport chain (ETC) disruptions and improves mitochondrial oxidative
metabolism. Building on recent breakthroughs from our group, we will test the hypothesis that increasing
mitochondrial O2•– dismutation in renal tubular cells will reduce cisplatin-induced renal injury and promote renal
repair by reversing mitochondrial ETC disruptions and increasing NADPH regeneration by the pentose
phosphate pathway. In Aim 1, we will determine how tubular mitochondrial O2•– mediated interactions with ETC
complex II disrupt mitochondrial ETC function in cisplatin-induced CKD. In Aim 2, we will establish how O2•–
dismutation impacts renal NADPH metabolism in cisplatin-induced repair. In Aim 3, we will determine renal
biomarkers that predict the beneficial effects of GC4419 in vivo. The overall objective of this proposal is to
increase our understanding of how tubular O2•– dismutation protects from cisplatin-induced CKD and to develop
translational tools that will facilitate risk stratification strategies for future SOD-mimetic clinical trial design in
patients fighting cancer with Cisplatin. To that end, we will incorporate the following innovative methods using 1)
newly developed mouse model to delete mitochondrial SOD in tubular cells for pre-clinical studies, 2) novel
experimental design to interrogate the link between renal metabolomic adaptations, oxidant formation, and
antioxidant responses in cisplatin-induced CKD mouse models; 3) the mitochondrially targeted SOD mimetic
(GC4419) currently pending approval by the US FDA in patients undergoing Cisplatin treatment, and
4) evaluating tubulointerstitial injury biomarkers to facilitate risk stratification strategies for future clinical trial
design. If successful, this proposal will translate into novel diagnostic and therapeutic approaches to promote
renal repair in cisplatin-induced kidney toxicity.

Public health relevance
NARRATIVE (PUBLIC HEALTH RELEVANCE) Cisplatin is a very effective cancer therapy drug, but it is associated with development of chronic kidney disease (CKD) in up to 65% of the patients resulting in a significant public health burden of reduced long-term health and quality of life that remains unaddressed. Understanding how manipulating tubular O2•– dismutation in Cisplatin- induced CKD impacts mitochondrial function is expected to provide essential data needed for future clinical trial design to reduce CKD burden. This proposal is relevant to the NIH-NIDDK's mission to conduct and support medical research to improve people's health and quality of life using innovative methods, pre-clinically relevant models, and translational tools to develop approaches for repairing damaged tissues, i.e., Cisplatin-damaged kidney tissues.